ADHD and Sleep: Evaluating the Impact of Drug-Drug and Drug-Disease Interactions to Inform Care

Project Summary/Abstract
An increasing percentage of youth in the US report inadequate sleep and sleep problems, which negatively
impact health and daily living, leading to the development and worsening of psychiatric and non-psychiatric
health conditions. Individuals with ADHD suffer from sleep problems at higher rates compared to the general
population, with sleep disturbances one of the most frequent adverse effects of stimulants, the primary ADHD
treatment. Despite inadequate evidence on safety, a variety of medications are prescribed to treat sleep
problems in youth. This proposal focuses on five commonly prescribed medications for sleep problems:
trazodone, benzodiazepines, nonbenzodiazepine sedative hypnotics, alpha-blockers, and hydroxyzine. None of
these are FDA-approved for pediatric insomnia. The safety of pharmaceuticals prescribed for sleep problems in
youth is vastly under-researched, hampering treatment recommendations. Medications commonly prescribed for
sleep disorders have been linked to risks of suicide, unintentional overdose, cardiovascular events, and
hallucinations. However, these adverse outcomes have not been rigorously examined in youth. Further, risks
may be magnified in stimulant-treated youth with ADHD, given independent risks of stimulants and of having
ADHD. The proposed project is motivated by high rates of sleep problems and sleep medication use in youth,
especially among those with ADHD, combined with a paucity of drug safety information and the potential for
magnified risks in youth with ADHD. In this proposal, we will provide the first estimates for the safety of
prescription sleep medications in children, adolescents, and young adults with ADHD. The study team will use
two large, national administrative claims data sets (2001-2023) covering over half million privately and publicly
insured youth with ADHD starting one of the study medications. We will evaluate nationwide age-specific patterns
of prescription sleep medication use and dose-escalation in youth with ADHD (Aim 1) and determine the extent
to which prescription sleep medications increase the risk of a) suicide attempt, b) unintentional overdose, c)
cardiovascular complications, and d) hallucinations and whether stimulant treatment or ADHD magnify the risk
of these harms in youth (Aim 2). Lastly, we will use novel signal detection methods to discover and evaluate
new, biologically plausible adverse outcomes of prescription sleep medications in youth with ADHD (Aim 3). This
research will yield new mechanistic insights into drug safety and drug-stimulant and drug-ADHD interactions,
thus producing novel, generalizable, and actionable risk estimates of serious harms from prescription sleep
medications in youth with ADHD. Our findings will enable patients, caregivers, and clinicians to make
individualized evidence-based decisions concerning pharmacological management of sleep problems in youth.
The proposed methods offer a valid, timely, and effective approach to yield clinically relevant evidence and
support our long-term goal of generating rigorous safety data on sleep medications in youth with comorbid mental
illness.

Public health relevance
Project Narrative Youth with ADHD suffer from sleep problems at higher rates than the general population and may have increased risks for adverse outcomes with sleep medications. The proposed research will provide the first in-depth examination of how prescription sleep medications are used in youth with ADHD, estimate risks of serious adverse outcomes with sleep medications, and determine whether risks are magnified by ADHD and concurrent stimulant use. With sleep problems on the rise and increasingly recognized, it is of pressing public health importance to have information on sleep medication safety to guide treatment decisions for children, adolescents, and young adults.